Wearable Insoles for Recurrent Diabetic Ulcer Prevention (WIREDUP)

PROJECT SUMMARY
Diabetic foot ulcers (DFU) affect over 4 million adults with diabetes in the US. Adults with diabetes have a 30%
likelihood of developing a DFU during their lifetime and DFUs are associated with substantial morbidity and
mortality. More than 80% of all lower extremity amputations are the result of a DFU. The majority of DFUs have
a neuropathic etiology and appear on the plantar surface of the foot as the result of decreased sensation and
repetitive trauma. Prompt prevention and treatment of DFU is critical to decreasing amputation rates and
improving limb outcomes in patients with diabetes. Even after healing is achieved, DFU recurrence is common.
Up to 50% of adults with a history of DFU will develop a recurrent ulcer within one year of healing, and
approximately 70% of affected adults will develop a recurrent DFU within 5 years. The standard clinical
approach to DFU prevention includes regular foot examinations and offloading therapy, where patients with
healed DFU are given special shoes or insoles to redistribute plantar pressure points away from a previously
affected area of the foot. Even in a setting with proactive surveillance and offloading programs, one-year ulcer
recurrence is typically greater than 30%. Interactive sensory insoles (Orpyx Medical Technologies Inc.) is a
novel foot overload warning device designed to monitor gait parameters including plantar pressure, plantar
temperature, and step count in adults with diabetes. Unlike standard offloading therapy, interactive sensory
insoles provide real-time cues for pressure offloading to patients via a smartphone application, and transmit
data to healthcare providers via a HIPAA-compliant dashboard for concurrent remote patient monitoring. We
have completed a feasibility trial of interactive sensory insoles and demonstrated excellent usability and patient
engagement. However, it is unclear if this technology can reduce the risk of DFU recurrence in adults with
recently healed ulcers. We propose to assess the efficacy of using interactive sensory insoles for the
prevention of recurrent DFU in a single-blinded randomized controlled trial. Primary Aim 1: Determine whether
use of an interacgtive sensory insole with real-time patient feedback and remote patient monitoring can reduce
plantar DFU recurrence compared to standard offloading alone among adults with a recently healed DFU.
Secondary Aim 2: Assess patient-reported outcomes related to the use of interactive vs. non-interactive
sensory insoles. Exploratory Aim 3: Assess DFU-related healthcare charges for patients randomized to using
interactive vs. non-interactive sensory insoles. Impact: There is a critical need for better DFU prevention
strategies, particularly for high-risk patients with prior DFU. Existing clinical paradigms with basic foot
offloading and annual foot exams only minimally decrease the risk of recurrent DFU. Study results will provide
actionable data about the efficacy of using patient-interactive sensory insole technology to monitor and prevent
DFU formation in adults at high risk for diabetic foot complications, potentially changing the way DFU
prevention is approached moving forward.

Public health relevance
PROJECT NARRATIVE There is a critical need for better prevention strategies for diabetic foot ulcers (DFU), which affect over 4 million adults in the US. Existing clinical paradigms with basic foot offloading and annual physician foot exams only minimally decrease the risk of recurrent DFU. Study results will provide actionable data about the efficacy of using a novel patient-interactive insole technology to monitor and prevent DFU formation in adults at high risk for diabetic foot complications, potentially changing the way DFU prevention is approached moving forward.